Community Engagement Core

ABSTRACT
CEC
Per- and polyfluoroalkyl substances (PFAS) in drinking water are challenging environmental and public health
concerns for communities, policy makers, and scientists. PFAS are a broad chemical class representing over
3,000 chemicals; PFAS are valued for their non-stick properties and are used in many water- and stain-resistant
products, as well as fire-fighting foam. The multiple chemicals classified as PFAS and a lack of toxicological and
human health information make PFAS contamination a difficult issue for many communities to address. The
Cape Fear River basin is the largest river basin in North Carolina. It provides drinking water for more than 1.5
million people and has been impacted by PFAS contamination from many sources. This Superfund (SRP)
Center's Community Engagement Core (CEC) will work to help communities impacted by PFAS contamination
along the Cape Fear River become better equipped to address PFAS exposure as well as other environmental
health concerns. The CEC will engage community organizations who are currently working to address PFAS in
drinking water. We will work with these partners to measure social connectivity and assess and improve
environmental health literacy, so that residents can make informed prevention and intervention decisions for
improved environmental public health. Infrastructure, resources, and educational materials will be supplied by
the CEC in order to increase the capacity of community organizations. Environmental Health Fellows, student
Mini Grant research funding, and access to SRP analytical resources will support local research and engagement
efforts around PFAS. SRP researchers and trainees will participate in CEC training and programming to improve
their capability to collaborate with impacted communities. As best practices emerge, the CEC will contribute to
community-engaged scholarship.

Public health relevance
NARRATIVE CEC This Superfund (SRP) Center's Community Engagement Core (CEC) will work with communities along the Cape Fear River in North Carolina who are impacted by per- and polyfluoroalkyl substance (PFAS) contamination in drinking water. The CEC will help increase environmental health knowledge, so that residents can make decisions to reduce their exposure to PFAS, and advocate for a healthier environment.